Administrative Core

PROJECT SUMMARY
The Administrative Core will provide overall management of the CoBRE program. The specific aims of
the Administrative Core are as follows: 1) Provide administrative support to the CoBRE program, 2) Facilitate
scientific interactions and collaborations among Center investigators, 3) Facilitate effective mentoring of junior
investigators, 4) Recruit additional Center investigators, 5) Administer the Pilot Project Grant Program, 6)
Increase the visibility and membership of OCRID, and 7) Coordinate CoBRE program evaluation.